Biophysical Control of Cell Form and Function by Single Actomyosin Stress Fibers: Instrument Supplement

PROJECT SUMMARY/ABSTRACT
The objectives of our R01 award, Biophysical Control of Cell Form and Function by Single Actomyosin Stress
Fibers, are to investigate contributions of cofilin-1 to front-back mechanical polarization during migration and to
understand the role of stress fiber networks in confined migration. Our work takes advantage of a unique and
innovative combination of single-cell biophysics, computational modeling, molecular reconstitution, and use of
engineered culture platforms. These disparate methodologies all share a reliance on high-resolution optical
imaging of live cells, reconstituted assemblies, or combinations thereof. Our laboratory's live-cell imaging needs
are currently supported by a Nikon TE2000E2 system, which we purchased with institutional startup funds in
2006. While this system has served us very well over the past 17 years, it has been plagued of late by a series
of component failures as specific pieces of hardware reach the end of their natural lifetimes. Moreover, this
microscope system is now several generations out of date, complicating maintenance and making it increasingly
difficult to replace components as they fail. We therefore request an Administrative Supplement for
Equipment Purchases to support acquisition of a new Nikon Ti2-E inverted microscope with extended live-cell
imaging capabilities and total internal reflection fluorescence (TIRF) microscopy. This purchase will critically
facilitate the work in this award in three ways: (1) It will replace our existing Nikon TE2000E2 microscope system,
which we purchased nearly 20 years ago, has suffered from repeated component failures, and is no longer fully
serviced by the manufacturer or vendor. (2) TIRF capabilities will enable us to establish Aim 1 actin-cofilin
reconstitution studies – currently restricted to collaborator Bruce Goode's laboratory at Brandeis – in the Kumar
Lab at UC Berkeley. This will greatly expand our experimental bandwidth and allow cross-checking of key results
across two laboratories. (3) Extended (24-48h) live-cell TIRF will enable us to image SF remodeling events
during confined migration at far superior resolution than with conventional epifluorescence imaging and on a
time scale longer than would be practical in a confocal or two-photon system in a core facility. We will also be
able to integrate this system with an innovative microfluidic platform we are developing, which we are aiming to
integrate with -omics screens to understand the molecular basis of confined migration.

Public health relevance
PROJECT NARRATIVE With the support of our current award, we are investigating microscale mechanisms through which cells generate force and change shape during polarization and motility, particularly through confined spaces in tissue. Accomplishing these goals requires high-resolution and long-term live-cell imaging capabilities, and our laboratory's live-cell imaging system is nearly 20 years old and beginning to fail. We therefore request funding to support purchase of a brand new, state-of-the art optical imaging system that will greatly enhance our ability to execute and even transcend our originally proposed studies.